Administrative Core

With COBRE Phase 1 grant support, we established the Tulane University Translational Science Institute (TUTSI) and successfully achieved our goals of increasing the quality and quantity of clinical and translational research in cardiometabolic diseases at Tulane University. Among 12 COBRE Phase 1 Research Project Leaders (RPLs) and Pilot Project Leaders (PPLs), seven have received one or more peer-reviewed research grants from NIH and NSF. TUTSI investigators have published 310 peer-reviewed scientific articles (140 from RPLs and PPLs and 170 from other COBRE investigators and collaborators) supported by the COBRE Phase 1 grant (GM109036) between March 2016 and August 2021. The overall objective of this COBRE Phase 2 application is to further develop and strengthen the clinical and translational research infrastructure at Tulane University and to continuously expand and support a critical mass of investigators with expertise in clinical and translational research in cardiometabolic diseases. The Administrative Core will provide management and coordination to the RPLs, PPLs, Mentors, individual Research Projects, Clinical Research and Community Engagement Core, Bioinformatics and Biostatistics Core, Molecular Detection and Diagnostics Core, Program Steering Committee, and Internal and External Advisory Committees to reach the Center's goals. The overall objective of the Administrative Core is to provide administrative, fiscal, and scientific support to all components of the COBRE program and to mentor RPLs and PPLs for their transition to successful and competitive independent investigators. To achieve our program objectives, the specific aims of the Administrative Core are: 1) to provide administrative, fiscal, and scientific management and coordination of the COBRE program, 2) to provide RPLs with multidisciplinary team mentoring on their research project and career development and help ensure their long-term success as independent clinical and translational researchers, 3) to promote interdisciplinary collaboration through the COBRE Pilot Project Program, 4) to facilitate multidisciplinary and interdisciplinary collaboration among COBRE investigators and integration with other COBRE and IDeA-Clinical and Translational Research programs and Tulane’s university-wide research strategic plan, and 5) to conduct formative and summative evaluation of RPLs, PPLs, Mentors, and the COBRE program. The Administrative Core will play a critically important role in achieving the overall objective of this COBRE Phase 2 program to further enhance and grow the clinical and translational research infrastructure and team of successful and competitive independent investigators in clinical and translational research in cardiometabolic diseases at Tulane University. These efforts will position TUTSI to become a national and international leader in clinical and translational research in cardiometabolic diseases. As such, this COBRE program will ultimately contribute to reducing the burden of cardiometabolic diseases and improving the health of individuals and the public in Louisiana and beyond.